Aptamer-based biosensing probes for chemical imaging of multiple analytes at single cells

Project Summary/Abstract
The Lazenby lab is an electroanalytical research group dedicated to introducing and developing new imaging
modalities and sensing methodologies for the study of complex biological systems. Our research leverages the
capabilities of electrochemical techniques to measure molecules in real time, with spatial resolution across
various size scales. Electrochemical methods are suitable for examining redox-active analytes, but many
biologically significant molecules don’t exhibit redox activity, meaning they can’t directly undergo electron transfer
in a potential window that doesn’t oxidize or reduce the solvent (i.e. aqueous media). Also, selectivity and the
number of analytes that can be detected is governed by the formal potential of the analytes of interest and other
redox active species in solution. To broaden the scope of processes that can be monitored, our lab is building
new methods to map and measure concentrations of various analytes to be applied to a range of cell lines. We
are using aptamers as the biorecognition element in a variety of sensor platforms that take advantage of the
ability to measure non-redox active analytes. These aptamer-based sensors have high specificity and sensitivity
for a diverse range of analytes, including small molecules, drugs, metabolites, biomarkers and toxins. We are
advancing the field by integrating these aptamer-based sensors into scanned probe microscopies, wherein the
functionalized imaging probes will enable high spatial resolution mapping of both cellular and subcellular
structures. Our lab is building a suite of imaging techniques, using different types of scanned probe that include
aptamer-modified microelectrodes for mapping large areas, and aptamer-functionalized nanopipettes for probing
subcellular features with high precision, and with the ability to measuring redox active analytes using traditional
electrochemical methods. These capabilities are particularly well-suited for the study of complex biological
processes that are challenging to observe using conventional methods.
A key innovation in our lab’s approach is the multiplexing of these imaging probes, that enables the
simultaneous real-time detection of multiple analytes. This will enable the concentrations of multiple analytes to
be quantified, and even visualized, simultaneously by targeting where aptamers are immobilized on probes with
multiple elements and exploiting the fact that a single potential waveform can be uniformly applied to any sensor
of this type. Furthermore, we are coupling the sensors with ion conductance probes for topographic
measurements of cells, and with electrodes for the detection of redox active species, and with potentiometric
probes for local pH measurement. These integrated probes will greatly enhance our ability to study a broader
range of biological systems than can currently be studied using existing imaging and multiplexing strategies. The
outcomes of the proposed research have the potential to transform our understanding of complex biological
processes, which paves the way for novel diagnostic tools and therapeutic strategies.

Public health relevance
Project Narrative Advanced electroanalytical techniques are essential for addressing complex biological challenges, such as acquiring spatial information on cellular uptake and release, and the real-time detection of multiple neurotransmitters. The proposed imaging and sensing technologies will operate across various size scales to measure concentrations of small molecules in extracellular media, providing insights into the behavior of healthy and diseased cells. This approach has the potential to significantly enhance our understanding of disease mechanisms that are difficult to study with current imaging modalities, potentially leading to improved diagnoses strategies across a range of health conditions.